Monitoring the aging lung using genomics, proteomics and informatics

ABSTRACT_CORE B
The long-term health of the lung and other tissues is inextricably linked to the sustainability of the protein fold
and its function. Fold and function are tightly coupled to the energetic health of the cell. This is achieved by the
emerging paradigm of harmonization of cell function (DNA, RNA and protein) with protein homeostasis or
proteostasis, a collection of integrated biological pathways that generate, maintain and repair the proteome.
Efforts in the previous funding period revealed the importance of both proteostasis sensitive pathways and the
mitochondria in management of the aging lung, pathways that are responsive to the life-span extending drug
metformin that is thought to impact the function of mitochondrial complex I, and ISRIB, which our preliminary
data suggests accelerates lung repair in a variety of injury models.
In Core B, we will quantitatively track changes in proteostasis during recovery from influenza A-induced tissue
injury using integrated bulk and single cell RNA-Seq, spatial transcriptomics and rigorous mass spectrometry
(MS) approaches. We will apply these approaches to high quality flow cytometry sorted samples of lung, skeletal
muscle and brain tissue from aged mice provided by Core C. Our computational groups at Northwestern and
Scripps Research interact freely via shared electronic platforms. They will use these data to create a multi-
dimensional understanding of the impaired recovery from influenza A infection in older animals. Core B will
couple these powerful technologies with the genetic and pharmacologic studies the investigators propose to
manipulate mitochondrial complex I function, the integrated stress response and ATF4 over the lifespan. We will
support these important studies in aging biology by focusing on three Specific Aims:
Aim 1: To provide bulk and single cell RNA-Seq and spatial transcriptomic data using flow-sorted
cell populations and homogenized tissues provided by Core C.
Aim 2: To provide mass spectroscopy analyses from flow-sorted cell populations obtained from
the lung, brain and skeletal muscle of aged animals.
Aim 3. To use advanced machine learning and system science tools to couple genetic and
pharmacologic interventions during aging with multi-omic experimental data from aging animals.
While the methods employed in this Core are inherently unbiased, we take advantage of the special expertise
within this Core and the PPG to focus on proteostasis, macrophage biology and metabolism over the lifespan.
By providing simultaneous RNA-Seq and proteomic analysis of alveolar type II cells, alveolar macrophages,
Core B we will create a multi-omic genotype to phenotype map of tissue recovery after injury during aging that
will be broadly applicable to other environmental challenges that limit healthspan.

Public health relevance
PROJECT NARRATIVE It is not required per instructions stated on the Funding Opportunity Announcement PAR-18-297, Section IV. Application and Submission Information, Project, Research & Related Other Project Information (Core), “Project Narrative: Do not complete”.